Administrative Core

The Administrative Core (AC) will provide collaborative activity management for the entire proposed program. It
will coordinate and organize the meetings of the projects leaders, the Internal Advisory Committee, and
External Advisory Committee. The AC will be responsible for the implementation of decisions, corrective
actions, suggestions, and initiatives recommended by advisory committees. The AC will also provide tools and
platforms that will foster the integration, collaboration, and communication between project leaders and cores.
One of the key responsibilities of the AC will be to facilitate the integration of all three subcontractors
(University of California San Francisco, Stanford University, Johns Hopkins and Washington University) with
the rest of the group. The AC will also monitor the progress of individual projects as well as effectiveness of
shared resources usage, especially the Animal Core and Imaging - Phenotyping Core. The AC will also
facilitate all interactions and utilization of the bio-statistical and mathematical modeling services performed by
Dr. Kheyfets.

Public health relevance
The core will provide administrative support and the overall leadership for the scientific integration of all projects in the PPG. It is responsible for financial oversight of all projects and for direct communication with the University’s involved and with the NIH. The PI, Dr. Stenmark has significant experience in directing large multidisciplinary programs.